Cell and Molecular Biology Training Program

PROJECT SUMMARY/ABSTRACT
Cell and Molecular Biology (CMB) is a unique, interdisciplinary Ph.D. training program that allows students to
explore the diverse landscape of biomedical research at Duke University before committing to a specific area of
research focus. The required first-semester curriculum follows a modular format that promotes exploration; the
required spring curriculum focuses on experimental design and modern cell and molecular techniques. Students
must complete three research rotations during the first year, which become the basis for choosing a mentor for
thesis research. In the second year, a grant-writing course is required in the fall and a written thesis proposal
must be orally presented and defended by the end of the spring semester. Additional in-depth training is obtained
through elective courses and thesis research. Students receive extensive instruction in the Responsible Conduct
of Research and in Rigor and Reproducibility, which is integrated throughout graduate training, and lab-safety
training is required yearly. Student progress and milestones are tracked and assessed using an app-based
tracking tool developed at Duke. To enrich the training experience and promote teamwork, first-year students
are mentored by second-year students, students organize annual recruitment activities, and students
collaboratively plan a yearly Symposium that brings experts to campus and celebrates research
accomplishments of CMB students. The CMB program is led by a Director and a Director of Graduate Studies
who embody the breadth of scientific expertise within the program, are at different career stages and have
complementary strengths. Additional program oversight is provided by an Executive Committee that broadly
represents the constituent faculty. There are 110 CMB training faculty, each of whom is required to take
mentoring and diversity-equity-inclusion training before students can affiliate with the corresponding lab. CMB
receives 200-300 student applications yearly; GRE scores are not required, and applicants are reviewed using
a standardized, holistic rubric. There are currently 98 graduate students at Duke who matriculated through CMB,
70 of whom are training-grant eligible. This group size creates a strong social and intellectual network that
enhances scientific exchange and encourages the use of multidisciplinary approaches. Sixteen training slots are
requested to maintain this robust program size, with selected students to be supported by the grant in years two
and three. The average time-to-degree for CMB students is 6.0 years and extensive professional development
resources are available that emphasize the exposure to and preparation for diverse scientific careers. The
overarching goal of the CMB program is to provide all students with a safe, inclusive, equitable and rigorous
training experience that provides the technical, operational and professional skills needed to become
independent and valuable members of the biomedical workforce.

Public health relevance
PROJECT NARRATIVE The Cell and Molecular Biology program at Duke University is an interdisciplinary training program that allows graduate students to explore the rich and diverse landscape of biomedical research before committing to an area of focus. Through required and elective coursework, rigorous thesis research and diverse professional development resources, students are prepared for a range of careers that contribute to fundamental scientific knowledge and promote human health.